Investigation of obesity paradox for renal cell cancer: a multilevel approach from molecular to neighborhood impacts

PROJECT SUMMARY
The incidence of renal cell cancer (RCC) has been steadily increasing over the past three decades in the U.S.
and it remains the most lethal urological malignancy due to a lack of screening for early detection. While
excess body adiposity at the individual level is a recognized modifiable risk factor for RCC, the influences of
obesogenic factors beyond individual level, particularly the molecular mechanisms and neighborhood
environments, remain unexplored. In addition, the impact of body adiposity on RCC survival is debated, with
evidence suggesting lower mortality among obese patients (i.e., obesity paradox). The scientific objectives of
this proposal are to 1) investigate how adiposity-related factors at the molecular, individual, and neighborhood
levels interplay to influence the RCC continuum—incidence, tumor aggressiveness, and survival—to reveal
underlying mechanisms and uncover novel prevention avenues; 2) apply advanced causal inference methods
to elucidate the true impact of body adiposity on RCC survival, the obesity paradox phenomenon.
Aim 1 of this proposal will use causal mediation analysis with the UK Biobank (UKB) database to
identify biological pathways through which excess body adiposity increases RCC incidence. Aim 2 will
elucidate the true impact of body adiposity on RCC survival, examining life-course pre-diagnosis
anthropometrics in the NIH-AARP Diet and Health Study (AARP) as well as pre-diagnosis adiposity-related
biological pathways using the UKB. State-of-the-art causal inference methods will be implemented to
ameliorate confounding, selection bias, and reverse causation that were inadequately addressed in previous
studies. In addition, Aim 2 will explore how pre-diagnosis adiposity influences RCC aggressiveness, to test a
potential biological hypothesis for the obesity paradox. Aim 3 will investigate how neighborhood socioeconomic
characteristics and built environments that can promote weight gain (i.e., obesogenic environment) affect RCC
incidence, aggressiveness, and survival. This aim will implement advanced multilevel methods using data from
several large prospective cohort studies, including the AARP study, Nurses’ Health Study (1 and 2), and Health
Professional Follow-up Study. The proposed research seeks to unravel the multilevel impacts of adiposity-
related factors on the entire RCC continuum, providing insights for the underlying biological mechanisms and
multilevel prevention efforts to reduce RCC incidence and improve outcomes.
This research proposal is complemented by a career development plan that builds upon applicant’s
background in medicine, environmental health, and cancer epidemiology. Specifically, this career development
plan outlines new training in three areas: 1) molecular epidemiology in kidney cancer; 2) advanced causal
inference methods; 3) multilevel approach for cancer prevention. The combined research and training plan will
prepare the applicant for a successful independent research career identifying, evaluating, and implementing
multilevel interventions to prevent cancer and promote overall health.

Public health relevance
PROJECT NARRATIVE Individual excess body adiposity is a major contributor to the increasing incidence of renal cell cancer (RCC), yet little is known about adiposity-related factors beyond the individual level, and their impact on RCC survival remains controversial. The proposed research aims to investigate the roles of biological mechanisms, individual anthropometrics, and neighborhood obesogenic environments in RCC development, aggressiveness, and survival outcomes. By leveraging molecular epidemiology, causal inference, and multilevel methods, this project will shed light on the complex interplay of multilevel obesogenic factors across the RCC continuum and uncover novel intervention strategies to ameliorate the growing burden of RCC.